Supporting Undergraduate Research Experiences in Environmental Health (SURE-EH)

PROJECT SUMMARY
We propose to continue our highly successful undergraduate training program – Supporting Undergraduate
Research Experiences in Environmental Health (SURE-EH) – specifically geared to the National Institute of the
Environmental Health Science's (NIEHS’s) strategic goal of increasing the diversity of the environmental health
science workforce. SURE-EH provides environmental health science research experiences and educational
opportunities to at least four undergraduate students from diverse backgrounds per year from across the
University of Washington (UW). The UW is a world-class research institution that holds diversity as a core value.
As a leader in environmental health science research, UW is well-positioned to ensure there are numerous well-
qualified applicants to the program. Participants are typically selected at the end of their sophomore year and
remain in the program for two years, including two summers. They conduct hands-on environmental health
science-related research in one of the wide range of disciplines encouraged by NIEHS’ Strategic Plan. SURE-
EH facilitates academic opportunities to complement the research experience, including course
recommendations, seminars, workshops, and research symposia. These educational opportunities enhance the
breadth and depth of SURE-EH participants’ environmental health science training. SURE-EH trainees will learn
responsible conduct of research by participating in SURE-EH-sponsored summer training sessions and will be
directed to courses where they can learn about the ethical conduct of science. These educational opportunities
complement the research experience, and in combination with the outstanding and broad-based environmental
health science expertise of UW faculty, ensure the SURE-EH participants are well-positioned to become future
leaders in the field of environmental health sciences.

Public health relevance
PROJECT NARRATIVE NIEHS recognizes that promoting healthier lives involves discovering how the environment affects people. It is essential that the workers making these discoveries represent everyone, including individuals who are from backgrounds that are underrepresented in the environmental health research enterprise. The SURE-EH program will provide research experiences and educational opportunities in the environmental health sciences to University of Washington undergraduate students from diverse backgrounds.